New Methods for Therapeutic Development

Project Summary
The overarching goal of this proposal is the development of new reactions, and the reagents
that control them, to generate enantioenriched organic compounds. These products are
valuable precursors to more elaborate small molecules that are medicinal agents and/or more
complex biologically active natural products. The proposed methods target the concise
synthesis of secondary amines, tertiary amines, and vicinal diamines as single stereoisomers.
These methods are based on the development of bis(amidine) reagents that form chiral proton
complexes (a polar ionic hydrogen bond) when a strong acid is added, or when used with acidic
substrates. Exploration of a new catalyst design is also described, asking whether reactivity and
enantioselectivity can be managed using achiral species involved in the reaction. These studies
continue the successful application of bifunctional organocatalysts to the stereocontrolled
creation of structural and functional motifs that, while common, are otherwise difficult to prepare
using conventional alternatives. A hypothesis-driven approach is outlined to explore an entirely
new mode of activation that involves achiral Brønsted acid activators. A range of innovative
multicomponent coupling reactions will be developed using chiral proton catalysis as the means
to control enantioselection.
These studies have the potential to impact small molecule synthesis, and ultimately the
development of therapeutic agents. Moreover, the methods enable the metal-free production of
functionally dense, single enantiomer (and diastereomer) organic compounds.

Public health relevance
Project Narrative The development of small molecule organocatalysts based on chiral Brønsted acid catalysis, particularly those that enable the streamlined synthesis of complex small molecule therapeutics is an activity that ultimately promises low-cost medicines.